Delineating the role of SPP1+ macrophages in colorectal cancer metastasis

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-029. Metastatic colorectal cancer (mCRC) is the major cause of death from colon cancer and is
unresponsive to current approved immune checkpoint therapy. We have previously identified that tumor
associated macrophages (TAMs) in the tumor microenvironment (TME) of mCRCs are defined by high
expression of the marker gene SPP1. These TAMs interact with fibroblasts and immune cells in the TME and
generate a pro-tumorigenic niche that allows cancer to flourish at distant metastatic sites. However, our
understanding of the functional mechanisms by which SPP1+ TAMs promote colorectal cancer (CRC)
metastasis is limited.
Our study focuses on understanding the influence of SPP1+ TAMs in migration and invasion in mCRC.
Leveraging sophisticated three-dimensional multi-cellular microfluidic devices, we will investigate TAM
functions in physiological model systems that maintain the complexity of the metastatic TME. Our hypothesis is
that SPP1+ TAMs can migrate into metastatic niches and further promote tumor cell invasion through
physiological barriers such as the blood-brain barrier (BBB).
In Aim 1, we will compare the differences in migration potential of SPP1 +/+ and CRISPR knockout
SPP1 -/- macrophages in the presence of tumor cells. We will utilize advanced imaging techniques and time-
lapse microscopy in microfluidic models in the presence of extracellular matrix. We will also test if fibroblasts
have an additive role in promoting TAM migration.
Aim 2 investigates the contribution of SPP1+ TAMs to mCRC invasion through the BBB in brain
metastasis. We will investigate this in a microfluidic model that mimics the in vivo human BBB. We will also test
if this process can be inhibited by therapeutic interventions such as pirfenidone, an anti-fibrotic small molecule,
and an SPP1 neutralizing antibody.
Together, we will identify the mechanisms by which TAMs promote CRC metastasis and develop
strategies to inhibit them.

Public health relevance
PROJECT NARRATIVE Patients who have cancer that has spread to distant sites in the body have a poor prognosis. Macrophages are a type of cell that surrounds the cancer and supports its growth. We will understand how these macrophages enable cancers to grow in other organs in the body and test treatments against them.